Exhaled small RNA biomarkers to detect and monitor airway disease

ABSTRACT
“Exhaled small RNA biomarkers to detect and monitor airway disease”
Asthma and chronic obstructive pulmonary disease (COPD) together affect over 600 million people worldwide,
highlighting the need for development of novel tools for early diagnosis and intervention. Because airways
communicate directly with the external environment, airway-based sampling provides a unique opportunity to
capture lung disease-specific biomarkers. Therefore, we have opted to interrogate exhaled breath condensate
(EBC), and our multi-lab collaborative team has demonstrated that unfractionated EBC from >500 donors contain
intact microRNAs, measurable by both qPCR and next generation sequencing (NGS). More recently, using an
optimized antibody-based (anti-CD63) purification assay, we identified the presence of small exhaled exosomes
in EBC, confirmed by electron microscopy and nanoparticle tracking, western-blotting, and by small-RNA NGS.
Our pilot clinical analyses of exhaled-exosomes specimens suggest that our unique approach may allow
detection of significant asthma and COPD case-control discriminant signals, using qualitative and quantitative
RT-PCR. The next phase of our work is to technically refine the combined applicability of our optimized molecular
approaches, and to evaluate the identification of asthma/COPD-specific exhaled biomarkers at diagnosis and at
exacerbation, testing airway tissue-specific antibodies to select exhaled exosomes for analyses. In this R33
proposal, we hypothesize that the: Optimized recovery and quantification of EBC-derived small-RNA
biomarkers will advance non-invasive airway (asthma, COPD) disease case-control discrimination and
disease monitoring, beyond existing technology. For these NGS and qPCR small-RNA analyses and
validations, we will compare exhaled whole and exosome-partitioned EBC samples, select internal references,
cross-validate detection/quantification methods, and confirm airway level of origin of EBC biomarkers. We will
develop refined small/microRNA panels via NGS and qPCR, and introduce automation platforms for higher
throughput evaluation of clinical specimens in two case-control pilots. The primary impact of this R33 project will
be to refine the development of exhaled small/miRNA biomarkers for asthma and COPD detection, with intent to
identify early exacerbation discriminators. This study will establish the basis for a multi-institutional prospective
cohort validation for exhaled small nucleic acid biomarkers for these two common lung disorders.

Public health relevance
PROJECT NARRATIVE Asthma and chronic obstructive pulmonary disease (COPD) are each debilitating airway disorders, which require development of early diagnosis and intervention. We have interrogated exhaled breath condensate (EBC), and demonstrated that we can detect microRNAs, measurable by both PCR-based methods and by next generation sequencing, and demonstrated the presence of small exhaled exosomes - encapsulating nanoparticles - that have potential to provide precise lung tissue-specific biomarkers. The next phase of our work, proposed in this R33 project, is to technically refine our optimized molecular approaches, and to then evaluate the identification of asthma/COPD-specific exhaled small/microRNA biomarkers for diagnosis and with disease exacerbations. The intent is to establish the basis for a multi-institutional prospective cohort study of exhaled small nucleic acid biomarkers for early detection and monitoring of these two common lung disorders.